Mechanisms regulating afferent innervation in the dental pulp

Project Summary/Abstract
Since teeth are exposed to environmental stimuli, tooth innervation is crucial to their protection and usage
throughout the life of an organism. The tooth is primarily innervated with sensory nerve fibers from the
trigeminal ganglion (TG) that protect the tooth organ by relaying noxious stimuli. The dental pulp (DP) secretes
neurotrophic factors to guide axonal penetration and sprouting within the tooth during postnatal development in
a highly regulated manner. Research has shown that secreted phosphoprotein, osteopontin (OPN), promotes
neuronal migration, proliferation, and survival [2–6]. The long-term goal of this project is to understand the
mesenchymal-neuronal signals that promote and maintain sensory innervation of the teeth. The overall
objective is to determine the role of DP in regulating tooth innervation during development and regeneration.
Our central hypothesis is that Tgfbr2 in the dental mesenchyme governs paracrine signaling via OPN to guide
tooth sensory innervation. Our laboratory has established a mouse model in which Tgfbr2 is conditionally
deleted in odontoblast-producing mesenchyme using an osterix promoter driven Cre recombinase (Tgfbr2cko).
These mice survive postnatally but with significant defects in bones and teeth [7,8]. We performed an mRNA-
Seq analysis using control and mutant postnatal day 7 DP and found that neuronal maintenance and
developmental genes were most highly regulated, including OPN. Immunofluorescent images indicated
reduced innervation throughout the DP in Tgfbr2cko mice. Preliminary experiments with DP and primary TG
nerves demonstrated increased axonal sprouting when TG cells were cultured with DP. Guided by these data,
we will test our hypothesis with the following two specific aims: 1) test the hypothesis that Tgfbr2 is necessary
to promote sensory innervation; 2) test the hypothesis that OPN signaling from the DP guides sensory
innervation. In both aims, we propose to cross Tg(Thy1-YFP)16Jrs mice, which express a high level of YFP
throughout the nervous system [9] to optimize visualization of the neurons. Under the first aim, a well-
characterized neurite outgrowth assay will first be used to co-culture TG neurons with DP where Tgf signals
are manipulated in the DP. In the second part of the first aim, we will use an in vivo dental injury model and
investigate neuronal regeneration in Tgfbr2cko and WT mice. Under the second aim, we will similarly co-culture
TG neurons with OPN-deleted DP cells +/- TGF1 and Tgfbr2-deleted cells supplemented with recombinant
OPN to investigate developmental neurogenesis in the DP. We will perform the dental injury assay on OPN-/-
mice to examine the mechanisms driving neuronal regeneration. The proposed research is significant because
it is expected to advance and expand understanding of how DP cells protect the tooth organ via axonal
guidance mechanisms. Such information will enhance our understanding of the complex interplay of
mesenchymal-neuronal interactions in the tooth that could serve as a basis for future preventative, therapeutic,
and regenerative strategies in endodontics and improve the preservation of teeth.

Public health relevance
Project Narrative Teeth are protected from our daily activities with a high degree of sensory innervation to detect pressure, temperature and pain, yet dental caries and the associated pain responses are currently the most chronic disease in the USA [1]. We have established a mouse model in which Tgfbr2 is deleted in the dental mesenchyme and found neuronal development and function were highly regulated by the dental pulp. We propose to investigate the mesenchymal- neuronal crosstalk guided by Tgf to enhance our current understanding of tooth development and regeneration and provide new therapeutic targets for pain management and regenerative strategies.